Human 3D Neuro-Vascular Interaction and Meningeal Lymphatic Models with Application to Alzheimer’s Disease

PROJECT SUMMARY
As the elderly population increases, the number of people with Alzheimer's disease (AD) is rising rapidly. There
is, therefore, a growing interest in the development of in vitro human disease models to better understand and
study the physiological and pathological mechanisms associated with AD. Emerging evidence has implicated an
early breakdown of the BBB in AD patients, even before the cognitive decline and brain pathology. In addition,
meningeal lymphatics are responsible for clearance of Aβ peptides from the brain parenchyma, and disruption
of meningeal lymphatics in AD transgenic mice accelerates Aβ deposition in the meninges, aggravates
parenchymal Aβ accumulation, and induces cognitive impairment. Yet, our understanding of the role of fluid
transport across the BBB, through the brain parenchyma, and exiting via the lymphatic system is poorly
understood. Therefore, the development of physiologically realistic human neural cell culture models of AD with
a neurovascular unit and meningeal lymphatic vessels is urgently needed to dissect molecular mechanisms
underlying the pathogenic cascade of AD and accelerate the discovery of new AD drugs. Building on our
extensive set of preliminary and related studies, we propose to develop a three-dimensional (3D) in vitro model
by integrating BBB, meningeal lymphatics, and stem-cell-derived AD cell culture to closely mimic the AD brain
environment. With this model, we aim to identify AD-specific mechanisms underlying pathophysiological changes
in the BBB, meningeal lymphatics, and Aβ clearance. Our 3D AD model will be useful for not only studying the
mechanisms of AD progression but also for drug discovery in a human brain-like environment.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) represents one of the most significant healthcare problems in the aging population of the United States, but the contribution of the blood-brain barrier and meningeal lymphatics impairment in AD is yet to be fully elucidated. This is partly due to the lack of an effective and reliable model to capture the complex interactions between the various cellular components in the brain. Drawing upon our considerable experience in 3D modeling of AD in a dish, the BBB, and neurovascular units in vitro, we propose to create a comprehensive model of AD focusing on key interactions and the role of the BBB and meningeal lymphatics impairment in Aβ clearance to gain a deeper understanding of underlying mechanisms.